The Summer HIV/AIDS Research Program (SHARP)

PROJECT SUMMARY ABSTRACT
This is a renewal application for the Summer HIV/AIDS Research Program (SHARP) at the San Francisco
Department of Public Health (SFDPH). SHARP is a summer-long research experience for undergraduate
students who are underrepresented minorities (URMs) in science and medicine. SHARP aims to enhance
the diversity of the scientific workforce by training undergraduates to be a part of a community of scientists
dedicated to substance use and HIV research. Over the next five years, SHARP, grounded in Social
Cognitive Career Theory, will engage URM students in an applied research program to prepare them for
graduate or medical school, and ultimately, choose HIV and substance use-focused careers. The renewed
SHARP will build on a highly successful program launched in 2012 that integrates research, mentoring,
training, shadowing, and networking opportunities and add new program enhancements to facilitate strong
mentor-mentee relationships. In addition to recruiting potential SHARP scholars from local Bay Area colleges
and universities, we will add new strategies to recruit from Historic Black Colleges and Universities and
minority serving institutions throughout the country through direct outreach and leverage our established and
growing national network of career mentors. The 12-week summer program will select six scholars each
year. SHARP scholars will conduct an HIV and substance-use focused research project, aligned with
National Institute of Drug Abuse (NIDA) scientific priorities, under the close supervision of highly engaged
SHARP mentor teams comprised of senior and junior investigators who will receive enhanced training to
support their scholars. Scholars will participate in weekly seminars and eLearning covering research
methods, state-of-the-science HIV and substance use topics, the responsible conduct of research, rigor and
reproducibility, and professional skills, including public speaking and manuscript writing. Scholars will have
the opportunity to shadow research staff and engage in Photovoice – a digital storytelling method to capture
the scholars experience as a URM in research. Scholars will receive faculty and peer mentorship and be
linked to a cadre of career mentors from NIDA-supported URM investigators at the University of California,
San Francisco, and other academic institutions across the country. The summer will culminate in a SHARP
Research Symposium where scholars will present their research findings. To retain interest over time and
track outcomes, we are launching a new eNewsletter, webinars, and works-in-progress sessions for alumni
and establishing a social network and new learning management system to host SHARP curricular content.
Moreover, alumni will be encouraged to submit abstracts for presentation at local and national conferences
and prepare manuscripts for peer review. The SFDPH is a rich research environment, suitable to host a
program poised to attract the next generation of equity-focused substance use and HIV researchers.

Public health relevance
PROJECT NARRATIVE SHARP (Summer HIV/AIDS Research Program) is an innovative and highly-applied HIV and substance use summer research experience for undergraduates who are underrepresented in science and medicine. SHARP scholars engage in research under the mentorship of leading HIV investigators, engage in peer-to-peer support, didactics, workshops and lectures, and have opportunities to shadow and participate in community events and other learning experiences designed to inspire them to pursue further studies and careers in public health-oriented clinical, socio-behavioral, and community-focused research. SHARP is a pathway program that aims to train the next generation of scientists.